Genetic interaction screening in renal cell carcinoma

We have obtained 6 patient-derived renal cell carcinoma (RCC) cell lines harboring somatic mutations in metabolic genes from the lab of Marston Linehan (UOB/CCR/NCI). We have transduced those RCC lines with CRISPR-Cas nucleases amenable to our CHyMErA combinatorial genome perturbation platform. Expression of Cas nucleases have been verified by western blotting and work is in progress to assess editing efficiency of the cell lines. Once cell lines have been validated through those assays and cell line identify have been confirmed by STR pofiling cell lines will be screened with genome-scale gene knockout libraries to identify fitness genes across the various genetic backgrounds.